Enhancing Imaging Efficiency through Automated Slide Scanning Image Acquisition

Title: Enhancing Imaging Efficiency through Automated Slide Scanning Image Acquisition
Abstract:
The McLaughlin Research Institute is requesting funds to purchase an APEXVIEW APX100 Benchtop
Fluorescence Microscope and slide scanner as an integral core component of our imaging suite. The
Institute’s mission to support researchers in addressing complex scientific problems in rural, aging
communities is built on a legacy of innovative biomedical research. As the closest biomedical
research institution to more than two thirds of the residents of Montana, we seek to bring science
opportunities and discoveries to communities across the state while doing groundbreaking science.
While the Institute has invested in high resolution confocal microscopy systems, these systems are
older, and significant advances have been made in the optics and automation systems available. The
existing microscopes lack critical features available in the new APX100 system. To address the lack
of critical features, we propose funds to purchase a system that incorporates an automated full slide
workflow, advanced deconvolution algorithms, enhanced z-stack acquisition parameters and large
area tissue scanning features. The current acquisition processes create bottlenecks for the diverse
NIH-funded projects at the Institute. The addition of this instrument would expedite research progress
through reduced acquisition and processing time in both established NIH funded projects as well as
new early-stage pilot projects from a recent partnership with the first medical school in the state. As
the closest biomedical research institution, geographically, to most of the state, this resource would fill
a technological void, substantially accelerating the progress of NIH funded projects. In summary, the
APX100 will stimulate effective and efficient imaging workflows enabling advancement of NIH-funded
projects at the McLaughlin Research Institute supporting scientific discovery in the understanding of
diseases affecting rural and aging populations.

Public health relevance
Project Narrative/Public Health Relevance Statement: This proposal supports public health as it seeks to significantly enhance research capabilities in Montana through the acquisition of an automated microscope enabling higher throughput analysis of samples from diseases affecting rural and aging populations. The McLaughlin Research Institute is the only research facility in northcentral Montana, and increasing scientific capabilities promotes scientific progress and inquiry and inspires future discoveries.